Cilium-associated structures in rod cells

Rod and cone photoreceptors of the vertebrate retina detect light using their outer segments, highly specialized
forms of primary cilia. Primary ciliary throughout the body play important roles in sensing the cellular
environment, and genetic deletions in their molecular components, known as ciliopathies, lead to devastating
congenital diseases, including blinding forms of retinal degeneration. The goal of this project is to develop a
thorough understanding of the structural and molecular basis of primary cilium function, with a focus on the rod
sensory cilium, and to understand the molecular mechanisms of rod cell death in ciliopathies. We have
developed and applied innovative molecular-scale imaging approaches using fluorescence and electron
microscopy to this problem, and now propose to introduce additional improvements in the imaging technology
and to use them to test hypotheses about normal ciliary structures and mechanisms, and about
pathophysiological mechanisms in animal models of retinal ciliopathies. Specific Aims: 1. Use cryo-electron
tomography (cryo-ET) and recent developments in sub-tomogram averaging to determine the three-
dimensional structure to nanometer resolution of repeating structures of the rod cell connecting cilium and
basal body, including microtubule doublets and triplets, microtubule inner proteins, “Y-shaped links”, transition
fibers and appendages. Our goal is to apply recent developments in hardware and software to rod cells in both
wild type retinas and in animal models of retinal degeneration. 2. Use superresolution fluorescence to test
hypotheses about trafficking of specific proteins and about the roles of IFT (intraflagellar transport) particles
and the BBSome (a coat-forming protein complex implicated in the blinding ciliopathy, Bardet-Biedl syndrome)
in ciliary trafficking in rods. Two-color superresolution fluorescence and quantitative interaction analysis will be
used to assess putative interactions between IFT proteins or BBS proteins and outer segment membrane
proteins, as well as well as proteins normally excluded from the outer segment which mis-accumulate there in
BBS-deficient mice. These experiments will test the hypothesis that specific membrane proteins are actively
trafficked through the connecting cilium membrane through their association with IFT particles, whereas others
are transported via alternative routes and excluded proteins are actively removed by the BBSome. 3. Use
mouse models to test the hypotheses that CEP290 is a major component of the “Y-shaped links” extending
from the ciliary axoneme to the membrane, using superresolution fluorescence, conventional TEM, and cryo-
electron tomography with timed gene disruption or gene restoration at different developmental stages to
distinguish initiating as opposed to secondary events in the development of the pathophysiology of ciliopathies
associated with this protein

Public health relevance
Narrative This proposal is focused on understanding the structural link between genetic deficiencies and inherited diseases of the eyes and other tissues. Doing so will help us understand the mechanisms of retinal neurodegeneration and other cilium-associated pathologies and could lead to new therapeutic approaches.